Olfactory dysfunction as predictor of PM2.5 exposure progression to dementia

Ambient fine particulate matter (PM2.5) pollution not just correlates with Alzheimer’s disease (AD) and/or
AD-related dementia (ADRD) but is also estimated to account for the highest burden of dementias in high-
income countries. PM2.5 exposure is also associated with olfactory impairment (OI), and the latter is believed to
play a role in the development of AD/ADRD, albeit a causal role of OI in the development of AD/ADRD remains
to be determined and no publication has investigated the role of OI in PM2.5 exposure-related AD/ADRD yet.
Therefore, to ascertain the causality between OI and AD/ADRD in our state-of-the-art modeling of PM2.5
pollution will obviously advance our understanding of the pathogenesis of both PM2.5 exposure-related and -
unrelated AD/ADRD and shed light on developing intervention approaches including early and accurate
diagnosis for AD/ADRD. Our preliminary studies in mouse models recapitulated the significant cognitive
decline due to chronic PM2.5 exposure, which was clearly preceded by OI and pathologies of the olfactory
epithelium (OE) and olfactory bulb (OB), not just supporting the causality between OI and AD/ADRD but also
making us technically ready to determine this causality. Through a synthesis of relevant publications and
several critical preliminary studies, we hypothesize that early after PM2.5 exposure, the cyclic GMP-AMP
synthase (cGAS)/stimulator of interferon genes (STING) /inhibitor B kinase 2 (IKK2)/nuclear factor-B (NF-
κB)-mediated inflammatory activation of the OE affects olfaction, heralding progression to late-onset
neurodegeneration and dementia, and propose to thoroughly test this hypothesis through pursuing the
following 3 relevant but relatively independent aims: Aim 1: Determine whether PM2.5 exposure-induced OI is
causal for the late-onset dementia; Aim 2: Determine whether PM2.5 exposure impairs olfaction and cognition
via the cGAS/STING/IKK2/NF-B axis-dependent inflammation and subsequent default neurogenesis in the
OE; Aim 3: Determine whether PM2.5 exposure alters odorant signal processing of the OB and whether
olfactory training promotes OB neurogenesis and ameliorates olfactory and cognitive impairments induced by
PM2.5 exposure. The overall objective of this proposal is to investigate the mechanisms underlying PM2.5
exposure-induced OI in a state-of-the-art PM2.5 exposure model and its correlation with late-onset dementia,
and our findings are expected to shed light on developing novel approaches for early and accurate diagnosis of
PM2.5 pollution-related OI as well as neurodegeneration and late-onset dementia.

Public health relevance
This proposal aims to investigate the molecular and cellular mechanisms of olfactory impairment (OI) in a state-of-the-art PM2.5 exposure mouse model and its correlation with late-onset dementia and is thus expected to shed light on developing novel approaches for early and accurate diagnosis of PM2.5 pollution- related olfactory impairment as well as neurodegeneration and dementia.